Early Life Stress and the Environmental Origins of Disease: a Population-based Prospective Longitudinal Study of Children in Rural Poverty (ECHO)

Project Summary/ Abstract
The inverse association between SES and health is well established. Its underlying causes are not. This
application leverages and extends an active prospective longitudinal cohort of children and families in rural
poverty to test key hypotheses about the ways in which early psychosocial and chemical exposures (0-5yrs)
adversely affect pediatric health outcomes in the areas of neurodevelopment and obesity. We describe an
ongoing population-based longitudinal study, the Family Life Project (FLP) with N=1292 children and their
primary and when available, secondary caregivers, followed from birth and oversampled for poverty and
African American ethnicity in predominantly low-income, non-urban counties in Pennsylvania and in North
Carolina. Participants were seen at 8 time points birth to 5 years and at 6 time points 7 to 13 years. A primary
focus of data collection and analysis has been the prospective investigation of associations between
psychosocial early life stress and neurodevelopment in the areas of executive function, emotion regulation,
tolerance for delay, language, school achievement, ADHD and LD. This application builds on and extends our
prior data collection retrospectively and prospectively in order to amplify and enhance our focus on adverse
exposures in relation to neurodevelopment and obesity risk. In the UG3 retrospective phase we expand our
investigation of chemical and neighborhood level exposures when study children were 0 to 5yrs. In the UH3
prospective phase we propose data collection during two clinic visits when children are 16 and 18yrs. These
visits will include the collection of all ECHO core elements plus biospecimens (blood, saliva, urine). With these
data we will develop clearly defined neurodevelopment and obesity phenotypes and test our primary
hypotheses linking early exposures to later health outcomes. We hypothesize direct effects of chemical and
psychosocial exposures on our phenotypes as well as mediation of exposures through effects of allostatic load
on the development of the central nervous system and the inflammatory processes of the immune system.
Importantly, follow-up of the FLP sample into late adolescence will provide much needed information with
which to reduce health disparities in high-risk, understudied rural populations. This follow-up will provide data
to address key questions about the rural context and individual differences relating to race, gender, and
geographic location that moderate relations between early exposures and later health outcomes. The FLP will
make a unique and valued contribution to the ECHO synthetic cohort. Inclusion of the FLP will allow for the
identification of factors that relate mechanistically to rural health outcomes and that can serve as the focus of
prevention and intervention efforts.

Public health relevance
Project Narrative This project addresses a topic of substantial public health relevance, namely the developmental origins of physical and mental health problems that underlie a wide range of high prevalence conditions that are heightened in the context of poverty, that are preventable, and that disproportionately burden the poor. It does . so using a predominantly low-income, rural prospective longitudinal sample to examine ways in which early life experience acting through biological and psychological mechanisms interacts with later experience to increase or decrease risk for adverse neurodevelopment and obesity outcomes